Progesterone receptors and migraine chronification

Migraines are typified by unilateral throbbing headaches and hypersensitivity to light, sound, and touch.
Migraines disproportionately affect women than men, particularly during the reproductive years. Female
reproductive hormones are proposed to regulate migraine pathophysiology. Frequent migraine episodes,
medication overuse, and incomplete relief from headaches from migraine therapies increase the risk of
episodic (EM) to chronic migraine (CM) transformation characterized by headaches occurring on 15 or more
days a month or headaches occurring despite anti-migraine therapies.
Progesterone activates progesterone receptors (PRs) and induces gene expression. PRs are widely expressed
in the brain, including in the migraine pain matrix. PR agonist treatment increased susceptibility to EM in
female mice; whereas, their deletion rendered a degree of protection. Based on these findings we propose to
test the hypothesis that PRs play a critical role in regulating the transition from episodic to chronic migraine and
that altering PR expression in relevant neuronal populations will affect this transformation. We will use mice
lacking PR expression in the central and peripheral nervous system, activity reporter TRAP2 (targeted
recombination in active neuronal population), and mice with a floxed first exon of Pgr (PRfl/fl) crossed with Fos-
CreER mice for these studies.
In the first aim, we will use alternate-day nitroglycerin (NTG) injections to induce experimental migraine
transformation. We will measure periorbital mechanical threshold, open field activity, and light aversion to
assess evoked and spontaneous pain. We will use PR agonist segesterone, antagonist RU-486, and PR
deletion in the central and peripheral nervous system to modulate PR signaling.
In the second aim, we will elucidate unbiased whole-brain maps of neuronal activity at a single-cell
resolution during the migraine transformation using TRAP2 mice and passive tissue clearing. We will
determine the neuronal populations consistently activated during EM and identify changes in neuronal
activation during migraine transformation. Finally, we will ablate PR expression in the neurons activated during
migraine and evaluate if this alters the migraine transformation.
These studies will provide insights into the role of PRs in regulating network transformation during migraine
chronification and also deepen our understanding of hormonal regulation of the default network alterations that
accompany chronic pain conditions, which are more prevalent in women.

Public health relevance
Project Narrative Women experience migraines more frequently than men, suggesting the role of female reproductive hormones in regulating the underlying pathophysiology. Our preliminary studies indicate that progesterone receptors (PRs), which mediate the genomic effects of progesterone, may influence susceptibility to experimental episodic migraine (EM). We propose to test the hypothesis that PRs play a critical role in regulating the transition from episodic to chronic migraine and that altering PR expression in relevant neuronal populations will affect this transformation.